Substrates of Cul3 and Insomniac for Sleep and Memory

PROJECT SUMMARY Autism spectrum disorders are among the most common neurodevelopmental disorders, affecting 1 in 42 boys and 1 in 189 girls, and present an urgent and growing public health challenge. Numerous autism risk genes have been identified, yet it is not clear how mutations in single genes cause the diverse behavioral alterations in autism, including pervasive sleep disturbances and deficits in learning and cognition. We hypothesize that, at least for a subset of autism risk genes, the dysregulation of multiple downstream molecular pathways, some during neuronal development and others in the more mature brain, underlie distinct behavioral aspects of autism. Because many autism risk genes are highly conserved, animal models such as the fruit fly Drosophila represent an opportunity to leverage powerful genetic tools to dissect mechanisms underlying autism. Our studies in Drosophila demonstrated a link between the Cullin-3 (Cul3) ubiquitin ligase, the BTB adaptor protein Insomniac (Inc), and the regulation of sleep?wake cycles. Our proposed research will utilize genetic manipulations in Drosophila to elucidate mechanisms and substrates underlying the impact of Cul3-Inc complex on sleep and other behaviors. By improving our understanding of how alterations in cellular ubiquitination pathways contribute to sleep dysfunction and cognitive deficits, our studies may ultimately provide insight into the etiology of autism and other neurological disorders.

Public health relevance
PROJECT NARRATIVE Although we spend one third of our lives asleep, the molecular mechanisms that regulate sleep remain poorly understood. We will use genetic manipulations in Drosophila to determine whether dysregulation of a specific ubiquitination pathway associated with autism contributes to sleep dysfunction and memory defects, both of which are hallmarks of autism spectrum disorders. Because both this ubiquitination pathway and sleep itself are highly evolutionarily conserved, our studies may have broad implications for understanding how altered ubiquitination contributes to pathologically disrupted sleep, memory, and autism spectrum disorders in humans.